Dynamic and functional analysis of Enterococcus faecalis penicillin binding protein 4 pedestal domain

PROJECT SUMMARY/ABSTRACT:
Central line-associated bloodstream infections (CLABSI) are associated with increased patient
mortality, prolonged hospital stays, and increased cost burdens. Enterococci are intrinsically cephalosporin
resistant opportunistic pathogens that account for 16% of CLABSI cases. When a patient is treated with
cephalosporins, commensal enterococci in the gastrointestinal microbiome can flourish in the absence of
cephalosporin sensitive microbes. After proliferation, enterococci can then disseminate throughout the body
causing severe infections including CLABSI. Enterococci can acquire resistance to other antibiotics leading to
infections which are increasingly difficult to treat. As of 2021, the Center for Disease Control named
vancomycin-resistant enterococci a serious threat which caused an estimated 5,400 deaths. Within this
context, understanding the mechanism of intrinsic antibiotic resistance of enterococci has become paramount.
Through elucidating these mechanisms, we will lay the foundation to enable development of novel therapeutics
that disable intrinsic cephalosporin resistance and thus aid in the treatment of critically ill patients.
Enterococcus faecalis possesses three non-functionally redundant class B penicillin binding proteins
(bPBPs) which crosslink peptidoglycan in the final steps of peptidoglycan wall synthesis. Previous work has
shown that penicillin binding protein 4 (Pbp4), a bPBP, demonstrates low-reactivity to cephalosporins and is
required for cephalosporin resistance. While the catalytic activity of Pbp4 has been studied, there is a lack of
understanding of how non-catalytic domains of Pbp4 impact function. Through understanding the role of the
pedestal domain of Pbp4, we may be able to exploit these mechanisms to develop antimicrobials which disable
Pbp4 activity, thus resulting in cephalosporin sensitivity.
Overall, I hypothesize that the pedestal domain of Pbp4 plays role in regulating protein function
and therefore impacts enterococci cephalosporin resistance. To test this hypothesis, I propose two distinct
but complementary aims. Aim 1: To define and characterize protein-protein interactions between Pbp4 and
proposed binding partners in vitro and in vivo. Aim 2: To characterize Pbp4 pedestal domain mutations which
result in a cephalosporin-sensitive phenotype.
Through this proposed multidisciplinary project, I will gain mastery of biophysical, biochemical, and
bacterial genetic techniques. This experience housed within the Medical College of Wisconsin Medical
Scientist Training Program will provide opportunities for my growth into an independent physician scientist.

Public health relevance
PROJECT NARRATIVE: Enterococcus faecalis is an opportunistic pathogen which is intrinsically resistant to cephalosporins and can cause nosocomial central line-associated bloodstream infections which are often high-cost-burden and fatal. Penicillin binding protein 4 (Pbp4) displays low-reactivity to cephalosporins, and is required for cephalosporin resistance. This fellowship will use a multidisciplinary approach to further elucidate the role of Pbp4 in E. faecalis cephalosporin resistance, and may enable development of novel therapeutics which disable cephalosporin resistance to aid in the treatment of critically ill patients.